Administrative Core

CORE A PROJECT SUMMARY
Vascular diseases, and hypertension remains a major cause of mortality in the US. Furthermore, individuals
with metabolic syndromes are at an even greater risk of sequelae, such as a heart attack. While we have learned
significant information over the years on some of the factors that contribute to vascular disease, we have large
gaps in understanding about how specific cell types are recruited or activated in vascular lesions,
atherosclerosis, crosstalk between cell types, regulation of vascular tone, and how these might be altered by
metabolic conditions such as obesity. This overall program project addresses the intricate functions of key
membrane channel, Panx1, which link many of these steps (both in physiology and pathology); Our studies over
the ongoing funding period has already suggest that these channels are 'druggable' and can be relevant
hypertesion. The focus of this PO1 application is to understand the role of Pannexin channels in vascular
physiology and inflammation. Project 1 will study how Panx1 regulates inflammation in different tissue contexts.
Project 2 will investigate Panx1 expression in the vascular smooth muscle cells affects hypertension. Project 3
will address the role of Panx1 in cellular crosstalk in the context of diet-induced cadiometabolic syndrome.
Project 4 will address the mechanistic details of pannexin channel function using a variety of approaches. The
Mouse Core B will provide support for the overall animal studies, while the Cell Physiology Core Cwill help with
pannexin channel analysis in different cell types of relevance. The purpose of this Administrative Core
(Core A) is to coordinate the different parts of this PPG by providing scientific administration, grant and fiscal
management, statistical and computer/data support, and overall coordination of internal and external scientific
advisory meetings.